Cannabinoid Receptor Interacting Protein 1a (CRIP1a) in cell signaling and cargo transport

PROJECT SUMMARY
This new F31 proposal is to support the career development of Erin Hughes who will receive training in
cannabinoid receptor biochemical neuropharmacology with Drs. Howlett and Lowther. Recent years have seen
a global increase in the usage of marijuana containing the psychoactive constituent Δ9-tetrahydrocannabinol, a
partial agonist of the CB1 cannabinoid receptor (CB1R). The CB1R is a G-protein coupled receptor (GPCR) found
in the central nervous system and modulates neuroprogenitor development, neural commitment and migration,
and neurotransmitter release. GPCR function is dependent upon the ability to change conformations and to
transduce a response via G-proteins. This process requires association of a Gα-GDP subunit with Gβγ subunits
to form a heterotrimeric G-protein complex that binds to the GPCR. Stimulation of CB1R initiates the exchange
of GDP for GTP bound to Gα, activating the G-protein heterotrimer, and releasing the Gα and Gβγ subunits. The
released G-protein subunits propagate the signaling cascade through various interactions. Cannabinoid receptor
interacting protein 1a (CRIP1a) is a protein found in human neurons at various brain regions, which suppresses
CB1R cellular signaling via modulating G-protein activation. The Scientific Premise is that CRIP1a modulation
of CB1R can be understood providing us with an in-depth view of the role of CB1R in neuronal cell
signaling. CRIP1a can modulate the type of Gα subunit bound to CB1R, however the mechanism of switching
is unknown. Previous immunoprecipitation studies demonstrated that the CB1R C-terminal region interacts with
CRIP1a, and therefore one possible explanation for CRIP1a-mediated Gα switching may involve formation of a
ternary complex between CB1R, subtype-specific Gα proteins, and CRIP1a. The Lowther-Howlett collaboration
has determined the high-resolution structure of CRIP1a by X-ray crystallography and found that CRIP1a is a
member of the family of carriers for myristoylated or isoprenylated proteins. Based on the knowledge of the
structure and function of CRIP1a, I hypothesize that CRIP1a binds N-terminally myristoylated cargo
proteins, such as Gαi proteins. I propose to investigate CRIP1a interactions in the N18TG2 neuroblastoma
cell model which endogenously expresses the CB1R and associated proteins. The aims of this project are to
determine (i) the regulation of the CRIP1a- Gα interaction during agonist stimulation and heterotrimeric
G protein dissociation and the cellular localization of such interactions; and (ii) the role of palmitoylation
and myristoylation on G-protein interaction with CRIP1a. The results of the proposed studies will prove to
be transformative for the field by characterizing a new class of cargo carrying proteins and providing evidence
that will advance our understanding of how, when and where CRIP1a interactions modulate CB1R pathways.

Public health relevance
PROJECT NARRATIVE The legalization of cannabis products has led to an increase in the self-medication of medicinal marijuana by users who believe cannabis to be “perfectly safe”, notwithstanding the impact cannabis components have on neuronal development. This project explores the modulation of CB1 cannabinoid receptor (CB1R) by its cellular protein partner Cannabinoid Receptor Interacting Protein 1a (CRIP1a), a protein associated with defects in neurosensory development and schizophrenia. Understanding the biochemistry of CRIP1a and its interaction with and mechanism of regulation of CB1R is essential for understanding the impact of cannabis usage.